Role of PGM-3 and SPE-56 in fertilization and egg activation

Project Summary/Abstract
Infertility impacts one in five couples globally. For many of these couples, the sperm and egg look
morphologically normal. This complicates determining treatments for infertility. Despite the societal burden of
infertility and the need for reproductive control through new contraceptive targets, the genes and molecules
required for fertilization particularly the genes on the egg side are still largely unknown. The persistent lack of
molecular mechanisms surrounding fertilization often hinders determining therapeutic interventions. There are
many reasons that it been difficult to find egg function genes. This spans from redundant gene function,
pleiotropy, lack of validation from biochemical approaches, and challenges in maintaining sterile mutants.
These challenges highlight the importance genetic approaches to understand the genes required for these
mechanisms. I will use the Caenorhabditis elegans model system to conduct this research as it has a high
percentage of genetic homology with mammals, a quick generation time, and robust genetic tools. To facilitate
the identification of egg function genes, I designed and validated a forward genetic screen in Caenorhabditis
elegans using newly available balancer chromosomes to isolate uncharacterized genes involved in egg binding
and fusion as well as factors required for egg activation/the oocyte to embryo transition. This proposal will
determine the molecular mechanism of several of these newly discovered genes. I propose the following
research aims: 1) Investigate the molecular function of PGM-3 in the oocyte 2) Explore the effects of a newly
identified sperm supplied factor required for egg activation 3) Characterize other new gamete function mutants
that were previously identified. This mentored postdoctoral period of funding will provide me with the time and
resources to learn super resolution microscopy and proximity labeling as well as the skills to navigate a career
as an independent researcher. These skills are essential for my future career development goals which include
obtaining a faculty position and leading my own research program. To facilitation completion of these goals, I
have established a scientific advisory committee and a career development mentoring committee. Each are
comprised of experts in my field to assist me in my training. I also propose taking a microscopy course to
ensure that I have formal training in this complex subject. The K99 portion of this award will take place at
Rutgers University which has both a robust research and career development infrastructure for postdoctoral
training. The K99/R00 funding mechanism will allow me to learn and apply novel technology to accelerate
discovery of the molecules required for fertilization.

Public health relevance
Project Narrative Understanding the necessary genetic components is important for deciphering the causes of infertility and designing new contraceptives. I have identified several new genes involved in fertilization in the Caenorhabditis elegans model system. This work will establish new genes involved in fertilization on the oocyte surface.